Informatics-enhanced Social Networks and Affiliation Processes (ISNAP) to promote risk reduction and early diagnosis of Alzheimer's and Related Dementias.

Modification of risky health behaviors to improve brain health and early detection of the disease are pivotal components to alleviate the burden of Alzheimer’s Disease and Related Dementias (ADRD). Both these components are shaped by individuals’ inter-personal and intra-personal ties. In the proposed research, we will seek to develop a methodological framework that enables us to (a) examine individual- and group-level dynamics associated with information-seeking and care-seeking behaviors in online and offline contexts for risk reduction and early detection of ADRD, and (b) model population-level dyadic characteristics and their relationship with individuals’ behavioral state/stage, and manifestation of sociobehavioral processes. Grounded in theories of human behavior, cognitive psychology, and network sciences, we will employ mixed-methods approach to analyze behavior dynamics related to ADRD risk reduction and early detection. Specifically, we will employ theories (e.g., Integrated Behavioral Model, Transtheoretical Model of Change, Care seeking delay model) and methods that facilitate granular (e.g., grounded theory analysis), high-throughput (e.g., natural language processing, deep learning), and collective (e.g., ego-centered networks, affiliation networks) modeling of information seeking and care seeking behaviors. While generally applicable, our methods will be developed to address risk factors associated with cognitive aging, ADRD risk reduction, and early detection. This research proposal will result in 1) novel methods to incorporate behavioral/care seeking stages and processes into network models of ADRD risk behavior dynamics and 2) new proposals for the development of multilevel interventions to support individuals engaging in modification of risky health behaviors and care seeking behaviors within and beyond ADRD domain.

Public health relevance
Our proposed research seeks to elucidate information-seeking phenomena, specifically for Alzheimer's Disease and Related Dementias (ADRD). By employing advanced methodologies in data science and social network analysis, the study aims to uncover the inter-personal and intra-personal mechanisms through which we can support ADRD risk-reducing and care-seeking efforts. The ultimate goal is to inform the development of more precise and targeted interventions and campaigns that can enhance health promotion and ADRD detection strategies within at-risk communities.